Persistence of an IL-4/IL-13 autocrine loop promotes fibrosis-mediated urinary voiding dysfunction

PROJECT SUMMARY - PROJECT 3
Lower urinary tract symptoms (LUTS) are a costly and potentially critical medical problem for millions of aging
men. This spectrum disorder encompasses symptoms such as weak stream, nocturia, incomplete emptying and
intermittent urination, all of which are indicative of lower urinary tract dysfunction (LUTD). Surgical ablation of
prostate tissue and medical approaches may improve urinary flow, but such treatments are not effective for all
men, can produce adverse effects that result in discontinuation of the therapeutic regimen, and do not abrogate
the risk for disease progression. If left untreated or treated ineffectively, LUTD can progress to bladder
dysfunction, which can lead to urinary retention, recurrent UTI, bladder calculi, and, eventually, renal impairment.
Work accomplished by the Macoska laboratory and this Center have shown that collagen accumulation around
the prostatic urethra consistent with tissue fibrosis is an untreated pathobiology contributing to LUTD. The
overarching goal of the O’Brien Center for Benign Urology Research is to identify mechanisms that result in
lower urinary tract dysfunction and prostate-related lower urinary tract symptoms (LUTS). New evidence
(presented in this application) indicates heterogeneity among peri-urethral collagen-producing cells as well as
inflammatory cells within the prostatic microenvironment. Inflammatory cells secrete a medley of pro-fibrotic
proteins into the prostatic microenvironment. Among these proteins, IL-4 and IL-13 are of particular interest
because they share a common signaling axis which, as shown here for the first time, establishes and perpetuates
an autocrine loop that activates JAK/STAT signaling to promote the expression and maintenance of IL-4, IL-13,
their cognate receptors, regulatory transcription factors, and ECM components, even in the absence of
inflammatory cells. Based on preliminary data presented here we hypothesize that some peri-urethral stromal
cell populations establish an IL-4/IL-13 axis that self-perpetuates, induces myofibroblast phenoconversion and
survival, and upregulates collagen accumulation, thereby promoting consequent urinary voiding dysfunction. To
test this hypothesis, Project 3 will: 1) Determine whether signaling through the IL-4 receptor creates a STAT6-
and GATA-3-mediated positive feedback loop; 2) Elucidate the mechanisms through which the IL-4/IL-13 axis
promotes myofibroblast phenoconversion and concordant collagen expression; 3) Determine whether IL-4
pathologically represses myofibroblast apoptosis and thereby promotes myofibroblast survival, and 4) Test
whether the IL-4/IL-13 signaling axis promotes lower urinary tract fibrosis and urinary voiding dysfunction in vivo.
The results of these preclinical studies will elucidate previously unknown interleukin-mediated molecular and
cellular mechanisms that promote lower urinary tract fibrosis and dysfunction. Using JAK/STAT inhibitors to
therapeutically target this potentially self-perpetuating mechanism may ‘break the cycle’ and successfully treat
recalcitrant peri-urethral prostatic fibrosis contributing to LUTD development and progression.

Public health relevance
PROJECT NARRATIVE A Project Narrative is not required for the Research Projects as per the funding opportunity announcement (RFA- DK-18-029) instructions.